MONITORING SURFACTANT USE IN THE NEONATAL INTENSIVE CARE UNIT

This study will characterize the experience with the use of surfactant therapy in the neonatal intensive care unit (NICU) at St. Louis Children's Hospital. The study is a chart review of infants in the NICU who received surfactants therapy and matched controls who did not receive surfactant. The review will characterize usage and adverse reactions.